Flow Cytometry Shared Resource

Flow Cytometry Shared Resource Summary
The mission of the Masonic Cancer Center (MCC) Flow Cytometry Shared Resource (FCSR) is to provide
comprehensive state-of-the-art services and training in all aspects of flow cytometry to MCC personnel in a
cost-effective manner. The FCSR has facilities in both the Masonic Cancer Research Building (MCRB) and the
Cancer and Cardiovascular Research Building (CCRB). Several years ago, the FCSR was one of several
independent flow cytometry facilities in the Academic Health Center (AHC) at the University of Minnesota; each
was administered by a separate Center, Department, or Institute. The directors of these facilities and AHC
leadership decided to merge the flow cytometry facilities under one administrative umbrella with centralized
financial support from the AHC. This new University Flow Cytometry Resource (UFCR) provided an economy
of scale, more funds to purchase equipment, and uniformity of support among the AHC centers and institutes
that require flow cytometry equipment and expertise. It also allowed MCC researchers not housed in MCRB or
CCRB to access flow cytometry facilities other than FCSR and still receive an MCC subsidy for equipment use.
The FCSR is the largest of the 4 members in the UFCR consortium in terms of usage (approximately 80% of
billed hours) and instrumentation (7 of 10 flow cytometers, 2 of 3 cell sorters, and 2 of 2 data analysis work
stations). The FCSR Director of Daily Operations is Mr. Paul Champoux; he is supported by 3 full-time
personnel, AHC administration, and a 5-member Board of Scientific Directors. Dr. Christopher Pennell serves
on this Board as the Scientific Director of Flow Cytometry for MCC. He has oversight for all cancer-related
projects that use FCSR, and decisions regarding FCSR or any of the other 3 UFCR members requires Dr.
Pennell's agreement; this ensures that FCSR, and UFCR as a whole, meet the flow cytometry needs of MCC
researchers. The FCSR regularly partners with industry leaders to test and adopt new flow cytometry
technologies, keeping it at the cutting-edge of flow cytometry. As a result, the FCSR has had instrumentation
retrofitted with new technologies prior to commercial availability. These advancements have benefitted
customers and provided tools for the faculty to remain competitive with their peers, all at very low expense.
The specific aims for the next 5 years are to 1) provide MCC researchers with 24/7 access to advanced flow
cytometric instruments; 2) aid MCC researchers in the design of flow cytometry experiments, data acquisition,
and data interpretation; 3) educate MCC researchers regarding the principles of flow cytometry and train users
on self-service analyzers; 4) beta-test new reagents and equipment and continually upgrade equipment; and 5)
share cutting-edge advancements in flow cytometry with MCC researchers.